PATIENT-SPECIFIC NARROW BEAM BREAST CT

Executive Summary
Opportunity - Breast cancer is the most common malignancy among women. Several technologies are used for screening
and diagnosis of this disease: Mammography, Tomosynthesis, Ultrasound, and MRI. Mammography and Tomosynthesis
not only cause discomfort to patients, but their outcome is also dependent on the patient’s breast density: breast density is
associated with reduced detection sensitivity in both imaging techniques. Ultrasound has a low-resolution, is highly user-
dependent, and can be time-consuming; MRI is prohibitively expensive and time-consuming. There is significant need,
therefore, for an imaging modality that addresses the limitations of the current screening and diagnostic imaging
technologies, prioritizes patient experience, and reduces health care costs of detecting cancer.
Solution - MALCOVA has designed and developed a minimum viable product of a Dedicated Breast CT system that
provides 3D images of both breasts, similar to breast MRI, in 30 seconds of scan time, at mammographic dose levels,
without applying breast compression. The scientific premise of our proprietary technology is based on narrow-beam CT
image acquisition - Malcova’s proprietary technology protected through two utility patents, already granted and fully owned
by Malcova.
The specific aims for the parent project of this I-Corps application are: Aim 1: Development of fluence modulation assembly
(this assembly modulates the fluence of x-rays to generate a narrow beam), Aim 2: Development of a line detector assembly
(which leads to preventing the acquisition of scattered photons), and Aim 3: Development of the image acquisition protocol
and synchronization of the beam modulation and line detector assemblies.
Achieving synchrony between these assemblies renders proof of concept of, and clarifies the unknowns for, decoupled
gantry development in Phase 2. So far, we have developed the image acquisition apparatus (see the following figure), and
are on track to finish the project on time (by the end of April 2022).
MALCOVA’s MVP. The concept is shown in left, with the photos of the developed prototype on right.
Upon completion of this Phase 1 project, our developed prototype will be capable of scanning a breast-like object with a
narrow beam design paradigm. In Phase 2, we will focus on optimization of a patient-table design to facilitate maximal
chest wall coverage and bilateral breast imaging. The final vision for our product is a simultaneous bilateral breast
cancer imaging platform ready for subsequent technology plug-ins such as integrated biopsy, computer aided
detection and diagnosis. With a product cost estimate akin to that of a Tomosynthesis unit, our technology will be
accessible to radiologic facilities, providing an effective screening tool, in particular, for women with dense breasts.

Public health relevance
Unmet need: Several challenges remain for cancer detection among women with dense breasts. Breast density is associated with reduced screening sensitivity and specificity and poor prognosis. Increased risk of cancer associated with breast density may be tied to these known issues. Breast density has garnered the attention of government as a public health concern. Currently, 31 states have laws mandating that women be notified of the implications of their breast density, thereby encouraging discussions between patients and physicians regarding the need for supplemental screening. The only available alternative to Mammography is Tomosynthesis. Studies have shown that despite the improvements in cancer detection rates for women with average densities, the gains are insignificant for dense breast subgroups. Therefore, a significant unmet need remains for an imaging modality that better serves those in the population with dense breasts. Competitive landscape: Currently, there is only one FDA-approved Dedicated Breast CT design available for diagnostics applications. Since receiving the FDA approval in 2015, the manufacturer (Koning Corporation, West Henrietta, NY) has sold less than 10 systems around the world (only 3 scanners are utilized clinically in the U.S.). Another available product (manufactured by Advanced Breast CT Gmbh, Erlangen, Germany) has received the CE mark and has sold three systems since 2018 in Europe. We believe the relatively low market success to date for these existing systems stems from their shortcomings in addressing the needs of the market: simultaneous bilateral breast imaging, similar to breast MRI. Our technology directly addresses this requirement. Some of the major players in the breast cancer screening market are Hologic Inc., GE Healthcare, Koninklijke Philips NV, Siemens Healthineers AG, Analogic Corporation, Canon Medical Systems Corporation and Fujifilm Corporation. We do believe that these companies, and not the current manufacturers of breast CT, are our primary competitors. Due to the numerous limitations in their Mammography/Tomosynthesis technologies, as described above, the market is in need of the solution we, Malcova, are providing. Our growth projection: Currently, the only alternative to Mammography in breast cancer screening is Tomosynthesis. Since receiving the FDA approval for screening applications in 2011 by Hologic, the market has rushed to adopt Tomosynthesis as the main screening tool. As of June 2020, 71% of certified facilities possessed at least one Tomosynthesis unit, and the market has now moved into late-stage adoption. The inherent advantage of our technology over Tomosynthesis remains to be its true-3D nature of images, and moreover, the ability to image both breasts at the same time. The sensitivity of Tomosynthesis in dense breasts remains to be on par with that of Mammography: less than 60%. Our technology directly addresses this limitation, while providing high quality images and delivering the same dose level as Mammography and Tomosynthesis. Therefore, we project a similar growth rate as Tomosynthesis. Market Size: Breast cancer radiology is the most active segment of Radiology ($15.9B), forming 23% of the overall industry in 2020 ($3.7B). It is projected to grow at an estimated compound annual growth rate of 8.1% until 20286. The size of the market is a mere reflection of the magnitude of the problem: the American Cancer Society estimates almost 300,000 new patients with malignant breast cancer cases and 45,000 deaths in U.S. will occur in 2021. U.S. market: Our product is ideal for implementation in the U.S. market, as it occupies the largest market share globally, and is not constrained by individual patient wealth or socioeconomic status. According to “Market Estimates and Trend Analysis: Breast Imaging Market” report by Grand View Research projects, the U.S. market will hold the largest market share (31.7 percent) for breast imaging technology by 2024. The single greatest factor backing this demand has been the Affordable Care Act (ACA). One of the key portions of the comprehensive healthcare reform law requires coverage of certain preventive services for all adults, women, and children at no cost to the consumer. Breast cancer screening falls under these provisions, and so private group and individual insurance plans, as well as state Medicaid expansion programs, must cover screening Mammography and Tomosynthesis every two years for women between the ages of 50 and 74. Last year, the American Medical Association released six new CPT codes for breast CT reimbursement. Upon receiving the premarket approval from FDA, we will target similar same reimbursement codes for our device. Revenue Model: B2B with an upfront cost paid by the customer, with an option for warranty and support. This model is on par with that of current cancer imaging technology vendors. Bargaining power of customers: Hospitals often negotiate product prices. The listing price of a Tomosynthesis is roughly $400,000. The intended price point of our system will be on par with that of Tomosynthesis. Per our calculations, the expected development cost for a single breast CT system based on our design is less than $120,000, providing a healthy margin of more than 75% to account for overhead and profit. The profit margin provides room for negotiation with buyers. Contact PD/PI: Ghazi, Peymon Project Narrative Page 8 Initially, we will be targeting hospitals and medical centers that specialize in breast cancer as our customers (the early adopters). These facilities typically conduct more than 20 screening procedures per unit per day, and so the timeframe for them to recoup the cost of investment in our equipment through procedural billing will be relatively short. These customers would have a quick return on investment, with the system paying for itself in less than a year through increased imaging costs reimbursed by insurance companies. In subsequent marketing phases, we would work with hospitals that conduct fewer diagnostic procedures, and due to lower recall rate, Malcova’s imaging system prices may need to shift. Bargaining power of suppliers: Supplier power is low as our marketing approach does not lend itself to scaling up, thus preventing supplier-side issues.